DOE Collaboration

This Memorandum of Understanding (MOU) is made between the Department of Energy (DOE) and the National Cancer Institute (NCI) (the “Parties”), for the purpose of establishing a framework for collaboration between the Parties and for pursuing specific collaborative projects. The Parties intend to collaborate through steering committees, working groups, and project teams to develop strategic plans, set priorities, and leverage resources and expertise from multiple sources, including the private sector, toward the goal of collaborative development of a shared technology ecosystem and targeted applications that will bring advanced computing capability to biomedical research and produce a transformation across the continuum of cancer research and, ultimately, in patient care and outcomes. Future collaborative activities may involve additional parties and will be implemented through separate agreements, as needed. Cures funded.